Effect of IL-4RαR576 variant on response to Dupilumab in children with Asthma

Abstract
Asthma is a major health problem worldwide whose prevalence has reached epidemic proportions and that
exacts a heavy toll of morbidity. The high prevalence of asthma over the last decades reflects the interaction of
susceptibility genes in affected individuals with environmental and life style changes ushered by the industrial
revolution. A hallmark of asthma is chronic inflammation and tissue remodeling. Concerted efforts have gone
into characterizing the asthmatic inflammatory response and establishing the underlying mechanisms that drive
and sustain it long-term. Asthma, a heterogeneous disorder in its phenotypic manifestations, encompasses
several disease endotypes, or underlying pathophysiologic mechanisms. Relevant to this proposal is a mixed
TH2/TH17 endotype characterized by mixed eosinophilic and neutrophilic inflammation in the airways and is
associated with more difficult to treat and steroid-resistant asthma. We have recently shown that an interleukin
4 receptor (IL-4R) variant associated with severe asthma, IL-4Rα-R576, uniquely drives mixed TH2/TH17 cell
inflammation in the airways, tightly segregating with asthmatics with this endotype. We have further determined
that the mechanism by which this variant promotes mixed TH2/TH17 inflammation involves IL-4-dependent
subversion of allergen-specific induced regulatory T (iTreg) cells into a TH17 cell-like phenotype, leading to their
degeneration into bona fide allergen-specific pathogenic TH17 cells. The IL-4Rα-R576 is associated with
severe and difficult to treat asthma, and is particularly common among inner city pediatric age asthmatics. We
established dose response relationships with IL-17 in comparing the wild type (Q576/Q576), heterozygous
mutant (Q576/R576), and homozygous (R576/R576) mutant alleles and asthma morbidity. These observations
provide the rationale to use IL-4R blockade with the anti-IL-4R monoclonal antibody (mAb) Dupilumab with the
dual purpose of interrupting the IL-4-dependent mixed TH2/TH17 cell inflammation and simultaneously restoring
tolerance. This proposal brings together investigators with deep expertise in allergic diseases, genetics and
tolerance to address the hypothesis that pediatric age asthmatics harboring this variant will manifest a
particular favorable response to Dupilumab and that the IL-4Rα-R576 variant drives mixed TH2/TH17 cell
inflammation in the airways by subverting allergen-specific induced T regulatory (iTreg) cell responses
into the TH17 cell lineage. We will also explore the potential of long-term tolerance. To investigate this
overarching hypothesis this trial and mechanistic studies are led by investigators recognized for their expertise
and with a proven track record of collaboration with each other. We will examine the clinical response of these
children to therapy based on genotype and examine the evolution of the T cell inflammatory and regulatory
responses in asthmatic children stratified by their IL-4R genotype treated with either placebo or Dupilumab.
These investigations promise precision medicine-guided effective therapy directed by the IL-4Rα-R576
genotype that specifically targets a disease-driving endotype in children with difficult to treat asthma.

Public health relevance
Narrative Asthma is a major health problem worldwide whose prevalence has reached epidemic proportions and that exacts a heavy toll of morbidity. The development of precision medicine-guided effective therapies is hampered by the lack of thorough understanding of disease mechanisms. This proposal builds on these findings by bringing together a team of experienced investigators to test the hypothesis that the IL-4Rα-R576 variant predicts a more favorable response in asthmatics treated with the humanized anti-IL-4R monoclonal antibody Dupilumab. These investigations promise effective targeting of therapy directed by the IL-4Rα-R576 genotype to potentially provide favorable long-term benefit in children with difficult to treat asthma.